Characterizing Cognitive Impairment in Schizophrenia via Computational Modeling a

DESCRIPTION (provided by applicant): The field of psychiatry has made substantial progress towards understanding mental illness using basic neuroscience methods, but the explanatory gap between cellular hypotheses and clinical phenomena remains vast. This gap is particularly evident in our understanding of schizophrenia, a devastating disorder whose core feature is disrupted cognition. Schizophrenia patients present with debilitating cognitive deficits, not adequately treated by available therapies. Understanding and restoring cognitive function is critical to improving patients' lives. One way to close this gap is to investigate the clinical phenomena by combining several scientific methodologies, at multiple levels of analysis. Therefore, this proposal broadly aims to align functional neuroimaging with biophysically-realistic computational models of neural function and to test model predictions using safe and reversible pharmacological manipulations in healthy volunteers. It further aims to directly compare findings to deficits observed in schizophrenia patients. Ultimately, the current proposal will bridge levels of explanation to mechanistically understand cognitive dysfunction in schizophrenia. One severely compromised cognitive operation in schizophrenia is working memory: the ability to temporarily hold and manipulate information in mind. Disruptions in working memory compromise patients' ability to track thoughts, ideas, and feelings, severely limiting even basic functioning. Although functional neuroimaging studies repeatedly link working memory disturbances to prefrontal dysfunction, synaptic mechanisms remain elusive. One leading hypothesis proposes disruption in the balance of excitation and inhibition in cortical micro-circuitry caused by hypo-function of the N-methyl-D-aspartate (NMDA) glutamate receptor. However, to test this hypothesis in relation to disrupted cognition, and to ultimately develop medications that alleviate cognitive dysfunction in schizophrenia, we need to go a step beyond neuroimaging. We need an understanding of working memory dysfunction at the level of cellular mechanisms, which is where treatments are developed. The specific aims of this proposal are: i) to extend an established biophysically-realistic computational model of working memory to 'mimic' hypothesized NMDA receptor pathology and use it to make behavioral and neural predictions regarding deficits observed in schizophrenia; ii) experimentally test those predictions using a leading safe pharmacological model of schizophrenia that perturbs the precise mechanism in healthy volunteers, namely transient NMDA antagonism via ketamine; iii) to relate these pharmacological results to deficits observed in patients using behavior and functional neuroimaging. The proposed project will close the explanatory gap and help develop a multi-level mechanistic understanding of cognitive dysfunction in schizophrenia. Ultimately, the success of this research will fertilize rationally-guided treatments and improve the lives of people suffering from this devastating disorder.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cognitive deficits represent a major source of functional impairment for individuals suffering from schizophrenia; however, current therapies for schizophrenia do not effectively treat cognitive deficits. Although advances have been made, mechanistic understanding of cognitive dysfunction in schizophrenia at the cellular level remains out of reach, which is crucial for restoring higher cognitive capacity through targeted treatments. This project aims to understand cellular-level hypotheses of cognitive dysfunction in humans through the combination of pharmacological neuroimaging and mathematical modeling of cognition developed from the level of cells, with the ultimate aim to facilitate rationally-guided cognitive treatments for this devastating illness. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Schizophrenia is associated with prominent disturbances in belief and perception. However, abnormal cognitive functioning [1] is a core feature of the illness [2]. Cognitive deficits can emerge before other cardinal symptoms [3, 4], persist throughout the course of the disorder and are not alleviated by available therapies [5]. Understanding and treating cognitive deficits in schizophrenia represents a key step towards improving patients' lives [2]. One cognitive function that is particularly associated with functional impairment in schizophrenia is working memory (WM) - the ability to temporarily hold information in mind and manipulate it [6]. Our environment is 'noisy' and optimal WM depends on 'shielding' internal representations from interference [7]. This 'filtering' ability is severely afected in schizophrenia [8] and compromised during WM operations [9, 10]. Progres in understanding the neural mechanisms behind these deficits has ben discouragingly slow, in part because of a vast explanatory gap between clinical observations and discoveries in neuroscience of WM. While functional neuroimaging (fMRI) tools consistently reveal activation differences in schizophrenia at the level of neural systems [11], the cellular mechanisms underlying these observed deficits remain elusive. One leading hypothesis argues for possible disruptions in the balance of excitation and inhibition in the cortical micro-circuitry resulting from hypo-function of the N-methyl-D-aspartate (NMDA) glutamate receptor [12]. To translate this hypothesis to understand disrupted cognition we need a mechanistic framework that explains phenomena observed across multiple levels of analysis. One way to achieve this goal involves aligning cognitive tasks with computational models of neural function that are developed at the level of cells and to test those predictions using complementary approaches: i) pharmacological manipulations that transiently and safely mimic the hypothesized neuropathology in healthy volunteers; and i) directly compare results to deficits observed in patients. While computational modeling of cognition in psychiatry has guided our predictions conceptually [13], the current proposal is distinguished by its foundation in a computational model rooted in neurophysiologic data and building on assumptions based on molecular and systems neuroscience. This proposal aims to harness such a biologically plausible model of WM [14], whose assumptions can be tested in fMRI studies of patients with schizophrenia and in psychopharmacologic studies in healthy humans. Success of this work wil provide the field with: i) an advance in our mechanistic understanding of cognitive deficits in schizophrenia; ii) a method for elucidating cellular-level hypotheses using human neuroimaging, and iii) the potential for iteratively testing novel treatments [13]. Specific Aim 1: To extend an established biologically realistic computational model of WM such that it includes hypothesized NMDA receptor pathology and to generate behavioral and neural predictions regarding WM disruptions in schizophrenia. The model is a local micro-circuit comprised of both recurrent excitation (E-E) and feedback inhibition (E-I) and is capable of representing WM delay activity as well as testing susceptibility to distraction [14]. We aim to modulate model parameters to reduce NMDA receptor function onto inhibitory (E-I) vs. excitatory (E-E) cells and assay model performance. Further, we wil implement transient distraction during maintenance of WM. We hypothesize that NMDA hypo-function onto inhibitory cells will confer more distractibility in the model. Specific Aim 2: To test the hypothesis that NMDA antagonism via ketamine administration in healthy volunteers results in WM filtering deficits in terms of behavior and prefrontal recruitment and that these results match the deficits observed in patients diagnosed with schizophrenia. We hypothesize more distractibility and lower activity in dorso-lateral prefrontal cortex during WM faced with distraction following ketamine administration (in Brodmann's areas 46/9, a neural signature of distractibility; see Prelim. Studies C.2). We also aim to collect data from patients diagnosed with schizophrenia. We hypothesize that both behavioral and neural effects induced via ketamine in healthy volunteers will mimic deficits observed in an independent group of schizophrenia patients recruited as part of this proposal (see Prelim. Studies) [9]. Specific Aim 3: To compare output from our computational model implementing NMDA hypo-function (Aim 1) to behavior and neural activation following ketamine manipulation in healthy volunteers and deficits found in schizophrenia patients (Aim 2). We will use a cognitive task that matches the task used in the model (see Approach). This allows explicit testing of model predictions against behavioral results. We predict that implementing reduced E-I manipulation in the model will match behavioral results obtained following ketamine administration in healthy volunteers and deficits found in patients. Further, using the computational model simulations will allow a comparison with fMRI readout (see Prelim. Studies C3). A critical innovative aspect of this design is modeling the very process that is compromised in neuropsychiatric illness (e.g. WM) at the synaptic level and testing it with neuroimaging while making clinically and behaviorally measurable predictions. If successful, this approach can elucidate mechanisms of cognitive dysfunction in schizophrenia at the level at which treatments are applied.